Cancer Research Training and Education Coordination

SUMMARY
Training and Education have been central to the mission of the Stanford Cancer Institute (SCI) since its inception.
Aligned with the SCI Strategic Plan, SCI Cancer Research Training and Education Coordination Core (CRTEC)
integrates and organizes resources to (1) coordinate and promote cancer training, education and career
development activities across the training continuum within the SCI and across Stanford University; (2) develop
and foster continuous quality improvement and evaluate the impact of CRTEC programs on training and
education; and (3) promote diversity and inclusion across all CRTEC activities. CRTEC provides SCI members
and their trainees with a central point of contact for cancer-related training and education across the Stanford
Schools of Medicine, Engineering, and Humanities & Sciences. CRTEC oversees a large portfolio of training
grants that include 4 NCI-funded and 14 other cancer-relevant T32 training programs and a new American
Cancer Society Institutional Research Pilot Grant program. The SCI Fellowship Program, in existence since
2014, provides a critical source of funding that enables trainees to complete their cancer research training while
applying for extramural support and transitioning to faculty appointments. During the current funding period, the
SCI has provided a total of $1.5 million from institutional funds to support 24 SCI fellows, of those 8 SCI fellows
hold cancer-focused K08 awards, and 9 SCI fellows have transitioned to faculty positions over the current funding
period. Educational activities sponsored by the SCI include an annual multi-day research symposium for
graduate students and postdoctoral fellows, currently in its twelfth year, a weekly seminar series in cancer
biology, and weekly oncology seminars focused on clinical and translational research. Programs are also in
place for high school students with an emphasis on underrepresented student groups and for Masters students,
including for those with existing MD degrees. Future plans include hosting an annual Junior Faculty Forum and
fostering interactions with SCI Community Outreach and Engagement (COE) to enhance community outreach.